Non-canonical mechanisms of gene regulation by the histone demethylase KDM5

Abstract
The lysine demethylase 5 (KDM5) family of transcriptional regulators are important for normal
development and their dysregulation is associated with intellectual disability and with several forms of
cancer. However, a lack of understanding of the normal physiological roles of KDM5 proteins has
hindered our understanding of how their loss or gain leads to disease states. Thus, the long-term goal
of these studies is to define the molecular mechanisms by which KDM5 regulates essential gene
regulatory programs using the genetically elegant model organism Drosophila. Specifically, we focus
on defining mechanisms of transcriptional regulation by KDM5 that are independent of its well-
established histone demethylase activity. The importance of illuminating demethylase-independent
gene regulatory mechanisms is highlighted by our observation that KDM5 carries out its essential
developmental activities separately from its enzymatic activity. However, the molecular mechanisms
underlying these non-canonical functions of KDM5 remain unknown. Our new data show that a region
within the C-terminus of KDM5 that has no previously known function is required for viability.
Moreover, interactome studies link the C-terminus of KDM5 to the non-specific lethal (NSL)
transcriptional activation complex. These and other data lead us to propose the central hypothesis
that a KDM5 interacts with the NSL complex to orchestrate gene expression programs needed for
animal survival. To test this, we will use a range of genetic, molecular and cell biological approaches
to define the target genes and pathways regulated by KDM5 that are critical for development, and to
determine the molecular links between KDM5, NSL and transcriptional regulation. This study is
innovative in our focus on defining demethylase-independent activities of KDM5 and our use of state-
of-the-art techniques. This work is significant because we will provide fundamental insights into KDM5
function that will be broadly relevant for our understanding of gene regulation by multi-domain
proteins. Our work is also expected to highlight potential mechanisms by which KDM5 dysregulation
could contribute to intellectual disability and/or cancer.

Public health relevance
Narrative Altered expression or function of KDM5 family genes can result in two clinical pathologies: cancer and intellectual disability. To understanding how dysregulation of KDM5 causes these disorders, we first require detailed knowledge of how these transcriptional regulators carry out their normal physiological functions in vivo, which is the goal of this research proposal.